The impact of dysbiosis and the IL-12/23 signaling axis on IBD-associated bone loss.

PROJECT SUMMARY/ABSTRACT
Inflammatory bowel disease (IBD) is characterized by severe gastrointestinal inflammation and changes in the
intestinal microbiota. Many IBD patients also experience extra-intestinal manifestations. Skeletal abnormalities
are a frequent extra-intestinal manifestation of IBD, and patients exhibit up to a 40% increased risk of incurring
fractures compared to the general population. Although many factors, including malabsorptive malnutrition and
glucocorticoid use, contribute to IBD-associated bone loss, nutritionally replete and glucocorticoid naive patients
remain susceptible to bone loss. While changes in both the intestinal microbiome and inflammatory
cytokines occur in IBD, the precise mechanisms of IBD-associated bone loss are unclear. We have
therefore established complementary mouse models of colitis-driven bone loss, and are uniquely positioned to
use skeletal specific genetic knockout mice to define inflammatory and microbiotic drivers of IBD-associated
bone loss. My preliminary data implicate the IL-12/23 signaling axis in the pathogenesis of bone loss during
colitis. Intriguingly, these cytokines share a common subunit, IL-12/23p40 (p40), yet exert opposing effects on
bone remodeling. IL-12 inhibits osteoclast differentiation, while IL-23 leads to bone resorption through enhanced
osteoclastogenesis. Dual blockade of IL-12/23 is used clinically via monoclonal p40 antibodies; however, the
effect of p40 blockade on bone remodeling during gastrointestinal inflammation is unclear. In addition to the
impact of cytokines on skeletal homeostasis, emerging evidence has identified the intestinal microbiome as a
regulator of bone remodeling. Many studies have characterized changes in the IBD intestinal microbiome and
demonstrated that these changes are transmitted systemically by crossing the gut epithelium. Importantly,
skeletal cells sense and respond to microbial components through pattern recognition receptors, many of which
are dependent on the adaptor protein, MyD88. The overarching hypothesis of this proposal is that 1) IL-12/23
signaling and 2) circulating microbial components impact skeletal homeostasis during gastrointestinal
inflammation. I will test this hypothesis with two complementary Specific Aims. In Specific Aim 1, I will define
the role of IL-12/23 signaling on direct and indirect osteoclastogenesis during colitis. In Specific Aim 2, I will
determine the impact of skeletal MyD88-dependent PRRs on colitis-associated bone loss. Successful completion
of the proposed experiments will elucidate fundamental mechanisms by which systemic cytokines and circulating
microbiota components impact bone biology during colitis and provide a platform to test the role of alternative
colitis-associated cytokines in pathologic bone loss. Furthermore, these studies will clarify how therapeutic IL-
12 and IL-23 dual blockade in patients with IBD impacts skeletal homeostasis. Collectively, this proposal will
investigate how the IL-12/23 signaling axis and the microbiome impact skeletal homeostasis during
gastrointestinal inflammation while providing the ideal training and mentorship to develop my future career as an
independent, NIH-funded pediatric physician-scientist.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel disease (IBD), which is characterized by severe gastrointestinal inflammation, alters skeletal homeostasis and profoundly increases risk of osteoporotic fracture. The precise mechanisms of IBD-associated bone loss are unclear, but emerging evidence highlights the capacity of inflammatory cytokines and the intestinal microbiome to regulate bone remodeling. The main objective of this research proposal is to determine the impact of specific cytokines and changes in the microbiome on skeletal homeostasis during gastrointestinal inflammation.